Isolating Targets with Existing Data to Prevent Teen Drug Use in Child Welfare

Abstract: The child welfare system may be the locus of a vicious circle of intergenerational substance use. In the U.S. some 8.3 million teens dependent on alcohol or otherwise needing treatment for substance use actually reside with substance-abusing parents who were maltreated as children. Maltreated children of parents who abuse substances are more likely to abuse substances in adulthood. Teens involved in CWS have an abundance of risk factors and few protective factors against substance abuse. Given the abundance of risk for CWS involved teens, CWS can serve as an important gateway to substance abuse prevention services. CWS has the potential to serve as a robust non-specialty service sector platform because it can facilitate targeting of high risk youth, sustain both preventive and substance abuse treatment programs, and allows for the capture of teens and their caregivers in a mandated treatment setting. The literature on predictors of substance use initiation and intensity among CWS involved teens is still emerging, as is the literature on prevention and treatment services. Therefore, the overall goal of the proposed research is to conduct analyses of an extant national probability cohort of child welfare involved teens to determine the prevalence and impact of substance use, predictors of substance abuse over the course of adolescent development, and the role that current child welfare services play in ameliorating substance use and abuse. To accomplish this goal, we propose a three year study in response to PAR-10-018, Accelerating the Pace of Drug Abuse Research Using Existing Epidemiology, Prevention, and Treatment Research Data, which highlights: 1) basic science development related to knowledge of risk and resilient trajectories of drug using behaviors among CWS teens; and 2) analyses of the organizational and system contexts that improve the accessibility, utilization, and, effectiveness of substance abuse prevention services within a non-specialty sector. The overall goal will be addressed by the following specific aims: 1) Investigate prevalence and longitudinal trajectories of initiation and intensity of substance use among teens in CWS; 2)Investigate predictors of substance use for teens in CWS; 3) Identify common points for entry into substance abuse services, service utilization patterns, and service utilization outcomes for teens in CWS; and 4) Develop a prevention intervention framework for selecting and fitting evidence based interventions to address substance use among CWS involved teens.

Public health relevance
Public Health Relevance: This study aims to provide: an account of the time points in children's lives when preventive intervention can be most efficacious; 2) provide an appraisal of sub-populations of CWS involved teens for whom addiction services will be most relevant based on personal risk factors, environmental vulnerabilities, and service utilization patterns; and 3) undergird child welfare as a potential preventive intervention platform. This work will inform efforts to develop and mount evidence based interventions on a child welfare platform in order to address the needs of this underserved, heavily burdened segment of the population at risk for substance abuse. __SpecificAimsTextDelimiter__ Specific Aims Adolescence is a crucial time for the prevention of substance use disorders, because substance use increases throughout adolescence until it peaks in young adulthood.1-3 There is a great deal of evidence linking child maltreatment (i.e. abuse and neglect) to substance use disorders.4 Diagnosable substance use disorders have consistently been found to be higher among youth in child welfare than in the general population.4-9 Previous studies have identified an abundance of demographic, psychosocial, and contextual risk factors for substance use among youth in child welfare and few protective factors against substance abuse.10 While CWS are intended, in part, to diminish maltreatment's negative impact on adolescents' substance use, experience in foster care or other out-of home placement has been associated with substance abuse in adulthood.11-13 The child welfare system may be the locus of a vicious circle of intergenerational substance use. Maltreated adolescents currently engaged in CWS are at high risk of becoming the next generation of adults with addiction problems and/or the next generation of abusive or neglectful parents.14 Given the abundance of risk for CWS involved teens, CWS can serve as an important gateway to substance abuse prevention services. Intervening through CWS offers an opportunity to provide primary and secondary preventive education and treatment that can promote positive transitions to adulthood.15 CWS has the potential to serve as a robust non-specialty service sector platform because it can facilitate targeting of high risk youth, sustain both preventive and substance abuse treatment programs, and allows for the capture of teens and their caregivers in a mandated treatment setting. The literature on predictors of substance use initiation and intensity among CWS involved teens is still emerging, as is the literature on prevention and treatment services. This creates a gap in the literature related to appropriate and efficacious prevention strategies for CWS involved teens. The overall goal of the proposed research is to conduct analyses of an extant national probability cohort of child welfare involved teens to determine the prevalence and impact of substance use, predictors of substance abuse over the course of adolescent development, and the role that current child welfare services play in ameliorating substance use and abuse. This work will inform efforts to develop and mount evidence based interventions on a child welfare platform in order to address the needs of this underserved, heavily burdened segment of the population at risk for substance abuse. To accomplish this goal, we propose a three year study in response to PAR-10-018, Accelerating the Pace of Drug Abuse Research Using Existing Epidemiology, Prevention, and Treatment Research Data, which highlights: 1) basic science development related to knowledge of risk and resilient trajectories of drug using behaviors among CWS teens; and 2) analyses of the organizational and system contexts that improve the accessibility, utilization, and, effectiveness of substance abuse prevention services within a non-specialty sector. In this revised R01 application from a new investigator, we detail a plan to test specific hypotheses building upon methods developed in the PI's NIDA funded R03 (1 R03 DA024976) to determine the significant factors that contribute to or ameliorate substance use risk behavior for CWS involved teens. The opportunity for this line of inquiry, not previously possible, is facilitated by data from the Administration for Children and Families sponsored National Survey of Child and Adolescent Well-Being I and II (NSCAW), the most comprehensive series of longitudinal studies ever undertaken of the child welfare system. Models developed and tested on the first national probability cohort will be validated on a second cohort nearly identical to but independent from the first cohort. The overall goal will be addressed by the following specific aims using the NSCAW database: 1. Investigate prevalence and longitudinal trajectories of initiation and intensity of substance use among teens in CWS. 2. Investigate predictors of substance use for teens in CWS. 3. Identify common points for entry into substance abuse services, service utilization patterns, and service utilization outcomes for teens in CWS. 4. Develop a prevention intervention framework for selecting and fitting evidence based interventions to address substance use among CWS involved teens. Successfully addressing these aims will: 1) provide an account of the time points in children's lives where it may be most effective to target preventive intervention; 2) provide an appraisal of sub-populations of CWS involved teens for whom addiction services will be most relevant based on personal risk factors, environmental vulnerabilities, and service utilization patterns; and 3) enable the exploration into child welfare as a potential preventive intervention platform.